Monitoring the Future: Drug Use and Lifestyles of American Youth

DESCRIPTION (provided by applicant): This application seeks a five-year continuation of the Monitoring the Future (MTF) study, an ongoing epidemiological and etiological research and reporting project begun in 1975. In addition to being a basic research study, MTF has become one of the nations most relied upon sources of information on emerging trends in illicit drug, alcohol, and tobacco use among American adolescents, college students, and young and middle-aged adults. Nationally representative samples of 8th-, 10th-, and 12th-grade students (about 47,000 students in 400 schools per year) will be surveyed annually from 2013 to 2017. A companion panel application seeks continuation of the mail follow-up surveys of high school graduates at modal ages 19-30, 35, 40, 45, 50, and now 55. (NIDA requests that the study seek continuation funding through two separate applications as it has done in the last two rounds.) The study's cohort-sequential longitudinal design permits the measurement and differentiation of three types of change-age (developmental), period (historical), and cohort. Each has different determinants, and MTF finds all three types of change occur for most drugs. Factors that may explain historical trends and cohort differences also are monitored. MTF is designed to document the developmental history and consequences of drug use and related attitudes from adolescence through middle adulthood, and to determine the individual and contextual characteristics and social role transitions that contribute to change and stability in both use and related attitudes. This work will be extended to new years, cohorts, and ages under this main application and the companion follow-up application. The study will examine the importance of many other hypothesized psychological, behavioral, and social determinants of drug use (including attitudes and beliefs, counter- advertising, role-modeling, and access), as well as a range of potential consequences (including physical and psychological health, status attainment, role performance, and drug abuse and dependence). Impacts of some policy changes will be evaluated, including those of the new FDA cigarette labeling requirements on adolescents and young adults. The investigators will pursue several new approaches for increasing the already extensive use of MTF data by other investigators. The study's very broad measurement covers (a) initiation, use, and cessation for over 50 categories and sub-categories of licit and illicit drugs, including alcohol and tobacco; (b) attitudes and beliefs about many of them, as well as perceived availability, peer norms, and norms among role model groups; (c) other behaviors and individual characteristics (delinquency, school performance, plans, aspirations, etc.); and (d) aspects of key social environments (home, work, school) and social role statuses, experiences, and transitions. Results will continue to elucidate drug use from adolescence through middle adulthood-including the introduction of new drugs-with major implications for the policy, research, treatment, and prevention agendas.

Public health relevance
Smoking, drinking, and illicit drug use are major sources of morbidity and mortality in the population, and all of these behaviors tend to begin in adolescence. Monitoring the Future has played a vital role in measuring, tracking, and understanding these behaviors among American adolescents from 1975 through 2012. This application is to continue this important work from 2012 through 2017 by conducting annual national surveys of representative samples of 8th-, 10th- and 12th-grade students, and interpreting the rich findings that result. The use of more than 50 new and established substances, and attitudes and beliefs about them, will be assessed, as will the individual characteristics and environmental conditions that relate to them.